Bioactive small molecule development

Highlighted collaborative efforts include 1) the first reported activators of the M2 isoform of pyruvate kinase which highlighted this enzymes control of the cancer cell metabolic state; 2) the 2R,6R-hydroxynorketamine metabolite which possesses striking antidepressant activity without the associated ketamine-like side effects; 3) a novel IIb3 antagonist Zalunfiban with a unique ion displacement-based mechanism that limits receptor conformational changes; and 4) a dual FLT3/IRAK4 inhibitor that possesses activity in acute myeloid leukemia (AML) and myelodysplastic syndromes (MDS).